Investigating the role of cannabinoid receptors in oligodendrocyte development

Project Summary
Myelin is the protective sheath that wraps around neuronal axons to facilitate fast, saltatory conduction,
maintain axon integrity, and provide metabolic support. It is made by specialized glial cells called
oligodendrocytes (OL) in the central nervous system (CNS). The importance of myelin is highlighted in
neurological diseases such as multiple sclerosis (MS), where disruption of myelin can result in improper
neuronal function and may ultimately lead to axonal degeneration along with other symptoms. While the
importance of myelin is thus evident, there are currently no treatment options to prevent or aid in remyelination,
in part because the molecular mechanisms of myelin formation are not fully understood. However, the
endocannabinoid system (ECS) has gained increasing interest as a potential target to treat several
neurological diseases, including MS. Yet there is no clear understanding in the relationship between the ECS
and OL development or myelination. Aiming to understand of the molecular mechanisms that drive OL
development and myelination, our lab conducted a proteomic analysis of cultured rat primary OLs in which
myelination was increased by genetic methods. Among the list of proteins that were significantly upregulated in
OLs with increased myelin were two ECS enzymes, FAAH1 and DAGL-. This increase occurred during OL
precursor (OPC) differentiation, suggesting the ECS may play a role at this stage of OL development. This
model is supported by my preliminary in vivo studies in zebrafish activating the ECS. For this proposal, I aim to
define the role of CB1 and CB2 in OL development and myelination through continued pharmacological
receptor manipulation, careful genomic analysis using CRISPR-Cas9 mediated genome editing, and precise
multidimensional receptor activation and live imaging. In Aim 1, I will use a range of pharmacological and
genetic approaches to dissect the roles of CB1 and CB2 in various stages of OL development and myelination.
In Aim 2, I will investigate the downstream signaling effects of CB1 activation through calcium imaging, using a
novel photocaged ligand that is genetically targeted to OL lineage cells.

Public health relevance
Project Narrative Myelin is essential for proper neuronal function and health, and disruption of myelin leads to neurological symptoms in diseases such as multiple sclerosis and peripheral neuropathies. Mounting evidence has demonstrated that the endocannabinoid system can serve as a potential target for future therapeutics, through its role in regulating myelination. This proposal will uncover the specific roles of the cannabinoid receptors in the biology of the cells that make myelin, using genetic and pharmacological approaches as well as innovative photopharmacological tools in zebrafish.